Epigenomics of Mutant p53

PROJECT SUMMARY
The primary objective of Core 1, “Epigenomics of mutant p53” is to provide state-of-the-art transcriptomic and
epigenomic experimental approaches, next generation sequencing (NGS) expertise, computational analysis and
bioinformatic tools for data visualization, and integration of large ‘omic datasets across all Projects of this PPG.
Core 1 will also establish a reference epigenome for key experimental systems shared across Projects.
Generation of chromatin states and complete transcriptomes will serve this PPG to develop novel hypotheses
and enhance our understanding of mutant p53 enrichment patterns genome-wide. Importantly, Core 1 will
standardize genomics techniques to ensure the highest quality data that can be directly compared across
Projects. Core 1 will also manage the central data hub GOGO53 (Guardian Of the Genome Omics) through
standardized bioinformatic analysis across all Projects. The Core will provide: 1) state-of-the art epigenomic
studies to identify regulatory elements and transcription factor networks operating in the context of WT and
mutant p53 (ATAC-seq, ChIP-seq, CUT&RUN/TAG), 2) integrated transcriptomic and epigenomic data to reveal
direct (vs. indirect) target genes and identify altered p53 networks, 3) single cell technologies for transcript
(scRNA-seq) and epigenetic (scATAC-seq) analyses, and 4) creation and maintenance of GOGO53, an
interactive web-based platform to allow integration of all datasets across all Projects available to PPG users.
These aims will apply to each Project individually, yet simultaneously promote synergy between the various
mechanisms of p53 being investigated. This, in turn, will facilitate an in-depth understanding of the epigenetic
and transcriptional mechanisms regulating aberrant oncogenic programs of mutant p53. In addition, the core will
provide statistical support for all NGS-related studies, computational resource management, and training.
Core 1 will be spearheaded by Dr. Emily Bernstein (Professor, Icahn School of Medicine at Mount Sinai), together
with co-investigator Dr. Dan Hasson (Associate Professor, ISMMS) and Lead Bioinformatician Dr. Deniz
Demircioglu (Assistant Professor, ISMMS). Dr. Bernstein has 20 years of experience in chromatin biology and
>15 years in cancer biology; Dr. Hasson has >10 years of experience in epigenomic experimental approaches
and computational genomics including designing computational pipelines, complex data analysis, and
interpreting data across numerous biological contexts; Dr. Demircioglu has extensive experience in developing
bioinformatic pipelines for NGS data analysis in the context of cancer. This strong and dedicated team, all located
on the same floor at ISMMS, will work closely together to provide first-rate service to this P01.

Public health relevance
PROJECT NARRATIVE The objective of Core 1 is to promote our understanding of mutant p53 biology in cancer outcomes across the projects of this PPG. Access to state-of-the-art epigenomic and transcriptomic experimental approaches, instrumentation and expertise, data analysis and bioinformatic tools for visualization and integration of large ‘omic datasets is essential to our understanding of p53 biology and will be greatly enhanced and accelerated by the resources provided by Core 1.